Role of Liver Fibrosis in Cognitive Impairment and Dementia

PROJECT SUMMARY/ABSTRACT
This is a K23 career development award application for Dr. Neal Parikh, a neurologist and junior
investigator pursuing patient-oriented research on the contribution of liver fibrosis to cognitive impairment and
dementia. Dr. Parikh seeks to develop expertise in two key content areas: 1) cognitive impairment and
Alzheimer’s disease and related dementias (ADRD), with a focus on neuroimaging correlates of ADRD and
mechanisms of cognitive impairment, and 2) chronic liver disease hepatology with a focus on liver fibrosis and
biomarkers. He also seeks to develop advanced skills in study design and statistical methods specific to the
study of ADRD. Dr. Parikh has assembled a mentoring team led by Dr. Costantino Iadecola, a neurologist with
expertise in the links between systemic factors and cognition, in addition to three co-mentors: Dr. David E.
Cohen, a hepatologist with expertise in chronic liver disease and liver metabolism, Dr. Mony de Leon, an
investigator with expertise in ADRD neuroimaging, and Dr. Rebecca Gottesman, a neurologist with expertise in
ADRD epidemiology. Based on emerging evidence and his preliminary data, Dr. Parikh’s central hypothesis is
that liver fibrosis is independently associated with cognitive impairment, dementia, and related neuroimaging
markers. Dr. Parikh will test this hypothesis in three specific aims. Specific Aim 1 will test the hypothesis that
liver fibrosis is associated with cognitive impairment, incident dementia risk, and related imaging markers at the
population level among 500,000 participants in the United Kingdom Biobank prospective cohort study. Specific
Aim 2 will test the hypothesis that liver fibrosis is associated with cortical β-amyloid deposition on florbetapir
position emission tomography (PET) imaging in a diverse, multi-center cohort of 346 nondemented participants
in an Atherosclerosis Risk in Communities-PET ancillary study. Specific Aim 3 will characterize the prevalence,
causes, and impact of subclinical liver fibrosis in a prospectively enrolled cohort of 120 patients with cognitive
impairment and dementia. The proposed aims will use multiple liver fibrosis markers and complementary
cognitive endpoints, spanning neuropsychological testing, adjudicated incident dementia outcomes, and
neuroimaging markers including white matter hyperintensity volume and cortical β-amyloid burden. The
proposed research is significant because it seeks to establish a novel risk factor for cognitive impairment and
dementia, thus raising the possibility of new liver-targeted preventive and therapeutic strategies in ADRD and
cognitive impairment broadly. The proposed research is innovative because it seeks to expand the paradigm of
multi-etiology cognitive impairment and dementia by establishing a role for liver fibrosis in cognition beyond
hepatic encephalopathy. Further, this work will bridge hepatology and neurology to address the burden of
neurological disease by adapting contemporary and nascent hepatology tools to neurological research.

Public health relevance
PROJECT NARRATIVE Age-related cognitive decline, cognitive impairment, and dementia are incompletely explained by current paradigms. The proposed projects seek to enhance our understanding of the role of liver fibrosis, a common systemic condition, in cognitive impairment and dementia, to inform future preventive and therapeutic strategies. The public health relevance is evident given the growing burden of cognitive impairment and dementia and the need to better understand the contribution of multiple etiologies to cognitive impairment and dementia – a priority set by the NINDS 2019 Alzheimer’s Disease-Related Dementias Summit.